Targeting dormant leukemia-initiating cells in T-cell acute lymphoblastic leukemia

PROJECT SUMMARY/ABSTRACT
Therapy resistance is a major barrier to long term remission in pediatric T-cell acute lymphoblastic leukemia (T-
ALL). The prognosis for children with relapsed or refractory disease is dismal. Leukemia-initiating cells (L-ICs)
regenerate disease upon transplantation into mice. They also recapitulate the immunophenotypic complexity of
the parent leukemia supporting that, as in normal hematopoiesis, there is a cellular hierarchy among leukemic
cells. Our laboratory has previously demonstrated that the L-IC is a committed thymocyte progenitor and resides
in the leukemic DN3 population, however, only a fraction of DN3 cells can give rise to disease. L-ICs rely on
NOTCH1-induced MYC signaling for survival. Recent studies identified dormant, therapy resistant L-ICs in both
murine models and T-ALL patient samples. The role of cell cycle restriction in L-IC latency is incompletely
understood. In an effort to uncover pathways that govern L-IC function, we performed single cell RNA-
sequencing on thymocytes at varying stages of T-cell leukemogenesis using our transgenic Tal1/Lmo2 model.
This approach identified a dormant DN3 cluster, marked by low Ki67 expression, which is observed in other
murine T-ALL samples. Dormant DN3 cells exhibit high Notch1, but low Myc expression. The transcriptional
signature of these cells shows enrichment of genes previously implicated in leukemia initiation or leukemia stem
cell function. Dormant DN3 cells show enrichment of the non-canonical Wnt receptor Ryk, which is reported to
maintain hematopoietic stem cell self-renewal by limiting proliferation and promoting quiescence. RYK is
overexpressed in primary pediatric T-ALL and in Tal1/Lmo2-induced murine T-ALL compared to healthy thymus.
This indicates that RYK may not be restricted to this rare subpopulation and moreover, there may be a
therapeutic window for RYK inhibition in relapsed T-ALL. The central hypothesis of this proposal is that dormant
DN3 cells are quiescent L-ICs that retain proliferative and differentiative capacity, which permits their therapy
tolerance and subsequent expansion during relapse. This proposal will identify a gene signature of dormant DN3
cells and uncover the potential role of these cells in T-ALL relapse by evaluating their L-IC function and
chemoresistance (Aim 1). Aim 2 will define the non-canonical WNT/RYK signaling network in T-ALL and uncover
the role of these pathways in dormant DN3 cells and L-IC function by testing whether inhibition of RYK reduces
the L-IC frequency of murine and patient T-ALL cells. Collectively, these studies will provide critical insight to T-
ALL heterogeneity and will lay the foundation for development of L-IC targeted therapy for relapsed disease.

Public health relevance
PROJECT NARRATIVE There is an urgent need to understand mechanisms that lead to T-cell acute lymphoblastic leukemia (T-ALL) relapse. This proposal will establish the contribution of dormant leukemia-initiating cells to therapy resistance and will determine if targeting the non-canonical WNT receptor RYK can be used to eliminate these cells and prevent T-ALL relapse.